ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Administrative Core The administrative core coordinates research and training objectives of the Center. The aims of this core are to provide administrative leadership, support for fiscal grant accounting and writing, meeting organization, oversight of the pilot project mechanism, facilitation of hiring of new faculty, construction and maintenance of a website, coordination and organization of data for assessment, statistical consultation, and assistance with compliance issues.